Sculpting Membrane Dynamics: Membrane-Remodeling Factors Shape Oligodendroglial Form and Function

Project Summary
Oligodendrocytes in the central nervous system wrap multilamellar compact myelin membranes around axons
and dramatically facilitate action potential propagation. Compromised myelination results in neurological deficits
in myelin diseases and nervous system injuries. However, myelin sheaths don't look the same. There is vast
morphological heterogeneity, and the morphological parameters of myelin sheaths play a key role in determining
axon conduction velocity and circuit functions and influencing behavior. Development, plasticity and repair of
neural circuits require proper (re)establishment of myelin profiles, which undoubtedly involves extensive
membrane remodeling to shape oligodendroglial form and function. Nevertheless, how membrane remodeling
is regulated during myelination is still poorly understood. In this proposed research, we focus on a family of
intracellular membrane-remodeling factors which can bind to and bend plasma membranes and contain
functional domains interacting with actin or actin regulators. They may thus act at the very forefront of membrane
morphological changes and represent a major, paradigm-shifting mechanism for oligodendroglial membrane
remodeling. Therefore, we propose that this group of membrane-binding factors regulate oligodendroglial
membrane remodeling and play a pivotal role in CNS myelination through (a) cell process elaboration, (b) initial
membrane enlargement, or (c) radial and (d) longitudinal membrane expansion, which in turn could regulate the
number of myelin sheaths per oligodendrocyte, sheath length, or myelin thickness and determine the extent of
myelination and myelin profiles. In this proposed research, we will (1) conduct expression profiling to identify the
factors in this protein family that are expressed in oligodendroglia and perform gain-of-function analysis to
determine their sufficiency to remodel the morphology of oligodendroglia and myelin sheaths, (2) perform loss-
of-function analysis to determine their necessity to establish proper morphological complexity of oligodendroglia
and shape CNS myelination, and (3) determine their necessity to promote proper remyelination kinetics using a
focal demyelination mouse model. Accomplishing the proposed aims will unravel the roles of these intrinsic
membrane-remodeling factors in oligodendroglia and CNS (re)myelination and may provide key insights into
how these molecules are regulated through neuron-glia interactions to shape the myelin landscape and fit the
need for proper neural circuit functions in the future.

Public health relevance
Project Narrative This proposed research focuses on the membrane-binding protein factors that regulate membrane remodeling involved in myelination in the central nervous system. Extensive membrane remodeling occurs during myelination, but its underlying molecular mechanisms are still poorly defined. Our proposed research will uncover the roles of these membrane-remodeling factors in myelination and provide profound implications for manipulating these proteins and the associated pathways to enhance remyelination in diseases and injuries.